BLR&D Research Career Scientist Award Application

Our laboratory is focused on understanding how mitochondrial function contributes to health and
disease. As the major energy generating organelle of the cell dysfunction of mitochondria has been
implicated in debilitating diseases prevalent in the VA patient population. These include, neurodegenerative
diseases (Parkinson's, Alzheimer's), diabetes, cancer, and heart disease. Altered mitochondrial
metabolism can result in changed levels of tricarboxylic (TCA) cycle metabolites, (such as succinate or
fumarate), that act as signaling molecules to promote a pro-inflammatory state. This can lead to changes in
gene transcription, through the induction of reactive oxygen species (ROS), stabilization of hypoxia-
inducible factor-1α (HIF-1α), or the nuclear factor erythroid-2-related factor-2 (Nrf2) transcription pathway
that responds to pro-inflammatory stress. Our laboratory investigates the structure and function of two
essential members of the mitochondrial respiratory chain both of which reduce ubiquinone (CoQ10) used by
the oxidative phosphorylation system to generate energy. We study the function of Complex I
(NADH:ubiquinone oxidoreductase) which is the largest membrane-bound component of the mitochondrion.
NADH generated by the TCA cycle is used by Complex I to reduce CoQ10 and this activity controls the
NADH/NAD+ ratio. The enzyme is regulated by a structural change near the membrane domain termed the
Active/De-Active (A/D) transition, which we first showed occurred in vivo. We also study succinate
dehydrogenase (SDH/Complex II) which is a membrane-bound heterotetramer of dual function. SDH
oxidizes succinate to fumarate in the TCA cycle while reducing CoQ10 for energy generation. Malfunction of
SDH results in accumulation of succinate in the cell which promotes inflammation. It has been shown that
inhibitors of SDH can have a positive effect in treating damage form ischemia/reperfusion in both stroke and
cardiac models. Our studies of SDH have shown how the reversible inhibitor malonate binds to the enzyme
and causes inhibition. We are now focused on understanding how we can regulate the activity and
structure of both Complexes I & II so that this information can be used to treat disease.
One model we will use is to investigate how TCA cycle metabolites can be used to treat traumatic
brain injury (TBI) or stroke. Dimethyl fumarate (DMF) is an approved drug for treating relapsing multiple
sclerosis and psoriasis and Dimethyl malonate (DMM) is a cell-permeable non-toxic compound which in
vivo can be used to inhibit SDH. We hypothesize that in the brain injury model that DMM will block
succinate accumulation following injury and prevent the signaling that produces ROS during
ischemia/reperfusion; thus, reducing inflammation, the severity of the injury, and enhance healing. We use
mouse models for these studies. We will also determine if the epigenetic modifier DMF can reduce the
inflammation caused by TBI thus lessening the severity of the injury and enhance neuro-regeneration.
We were the first to determine the x-ray structure of SDH and have provided major insight into its
catalytic mechanism and function. How the enzyme complex is assembled, however, remains and area of
intense investigation. We are now studying the assembly of human Complex II using known human
assembly factors, needed for incorporation of redox cofactors necessary for function of the enzyme. It has
been shown that when assembly is compromised this can lead to tumor formation in humans. We have had
success expressing and analyzing the three-dimensional structure of the human structural subunits of SDH
expressed in bacterial models. Thus, for the first time the structure of these assembly intermediates will be
known. This information is needed to develop small molecule inhibitors/activators that can be used for
treatment of diseases associated with mitochondrial dysfunction and control metabolite levels in cells.

Public health relevance
Mitochondria are the powerhouse of the cell providing most of the energy needed for the human body to function. A number of diseases prevalent in Veteran patient populations are associated with the malfunction of mitochondria. Diseases like Parkinson's, Alzheimer's, neurodegeneration, diabetes, heart disease, and cancer all are associated with a decline in mitochondrial function. Our laboratory studies the architecture and function of essential mitochondrial proteins. We are developing methods to identify how mitochondrial proteins assemble with their essential vitamin and mineral cofactors that are needed for proper function. These studies will lead to methods for early detection of changes in mitochondria that can lead to diagnoses and treatment of disease. Early warning of changes in mitochondrial function will lead to the development of ways to intervene to protect patients from these debilitating diseases.